Expanding the understanding of tRNA lifecycle under cellular stress

Project Summary/Abstract
Cellular stress response is a complex and cascading mechanism that affects a multitude of cellular functions
aiming on cell survival. Recent studies from the perspective of cellular stress response have expanded our
understanding of tRNA to be a diverse and multifunctional molecule. tRNA has been linked to cellular stress
response through specific cleavage in the form of tRNA halves (tRNA-derived stress-induced RNAs, or tiRNAs)
or smaller tRNA fragments. These tRNA-derived RNAs are commonly found in certain diseases, suggesting their
potential importance in disease progression. However, the function and regulation of these alternative tRNA
derivatives are not well understood. We hypothesize that tRNA cleavage is regulated by differential RNA
modification, and that tiRNAs act as signaling molecules to healthy cells. In the first aim of this study, we will
investigate how covalent modifications found in tRNA affect tiRNA synthesis by the RNase angiogenin. We will
determine this by two means: the first by directly measuring modifications in cleaved and uncleaved species
using mass spectrometry, and the second by looking at tiRNA-protein assosication in the presence and absence
of specific modifications. In the second aim of this study, we will test functionality of tiRNA by studying its
longevity inside and outside the cell, as well as probe the hypothesis that healthy neighboring cells respond to
exported tiRNA. This project will expand our understanding of the roles of tRNA in cellular stress, as well as
provide a more detailed information of the tRNA interactome and stress-modulated changes in life cycle.
Because of the role that tRNA plays in a multitude of cellular processes, expanding our knowledge of tRNA life
cycle has broad implications in the fields of RNA biology, cancer biology, and possibly early disease diagnostics.
This grant will provide not just the opportunity for research, but also a foundation in molecular biology techniques.
It will also allow me to pursue a new and developing field of research, different from my previous trainings, better
preparing me for a future as a PI. This research will take place at Brigham and Women’s Hospital in an open lab
space conducive to exchange of ideas and collaboration. Brigham and Women’s provides access to state-of-
the-art resources and equipment to complete this research.

Public health relevance
Project Narrative The long-term goal of this project is to expand our current knowledge of tRNA cleavage in the context of biological systems. tRNA cleavage occurs as a result of cellular stress, and the products have been linked to human disease, including cancers. By understanding the life cycle of tRNA cleavage products, we can better understand their physiological roles and potential to serve as a biological marker or therapeutic target.